Combined Methylation and Mutation to Predict Response to PARP Inhibitors

PROJECT SUMMARY/ABSTRACT
The overall goal of the current proposal is to develop a clinically useful predictor of PARP inhibitor (PARPi)
sensitivity/resistance to spare toxicities and cost for patients unlikely to derive benefit. Our hypothesis is that a
combined mutation and methylation analysis performed immediately before initiation of therapy will provide a
useful predictor of PARPi response. To test this hypothesis, our approach is to complete development of a
high throughput and quantitative methylation assay for key HR genes and refine our assays using banked
tumor tissues formalin fixed paraffin embedded (FFPE) neoplastic samples from phase II PARPi trials, then
test these assays using samples from 4 large phase III randomized controlled trials (RCT) in OC and BC that
employ three different PARPi. We propose three specific aims:
Aim 1: Develop a clinical grade, quantitative methylation assay and a combined methylation and
mutation assay (MMA) to define those BRCA wildtype cancers with best response to PARP inhibitors.
Aim 2: Validate the combined HRR mutation and methylation assay (MMA) as a predictor of PARPi
response in 2 randomized controlled trials of recurrent breast and ovarian cancer.
Aim 3: Validate MMA as a predictor of PARPi response in 2 randomized controlled trials for primary
treatment of advanced ovarian cancer.
Together, these studies will provide insight into mechanisms of PARPi sensitivity while developing a clinical
predictor for both breast and ovarian cancer, which could apply to other cancer types. These studies will lead
to more precise therapeutic application of PARP inhibitors, reducing toxicity and cost while maximizing patient
benefit.

Public health relevance
PROJECT NARRATIVE The overall goal of the current proposal is to develop and validate a combined mutation and methylation assay as a clinical predictor of PARP inhibitor response. We will develop and refine a quantitative methylation assay, then test whether combining methylation and mutation analyses can predict PARP inhibitor sensitivity in patients with BRCA wildtype cancers using clinical samples from 4 large randomized controlled trials in ovarian and breast cancer.